Local Delivery of AdipoRon to Treat Arthrofibrosis

ABSTRACT
Arthrofibrosis is a debilitating condition that limits joint motion and causes substantial pain. It is a common
complication (~5%) following routine total knee arthroplasty (TKA) and its symptoms are often resistant to
pharmacological treatments, physical therapy, and revision surgeries. While aberrant extracellular matrix
generation is the primary manifestation, the cellular and molecular effectors that trigger and sustain arthrofibrosis
have yet to be elucidated. As a result, there are no therapeutic interventions available to prevent or treat
arthrofibrosis following TKA. It is thus critical to establish non-surgical preventive and therapeutic modalities for
arthrofibrosis. The scientific premise of our study is that routine surgical trauma caused by index TKA alters
the local cellular environment, leading to loss of adipocytes and adipokines that inhibit myofibroblastogenesis
and the formation of excessive fibrotic tissue in the joint.
This application will address the central hypothesis that activation of the adiponectin cascade suppresses
myofibroblast-induced scar tissue formation in the knee. Our working model is that arthrofibrosis
development is promoted by the local absence of the adipose-derived hormone adiponectin. Preliminary data
from our group reveal that adiponectin expression is suppressed in arthrofibrotic knees and the synthetic
adiponectin mimetic AdipoRon exhibits anti-arthrofibrotic properties in vitro and in vivo. Our studies will (i) assess
whether local sustained release of AdipoRon can prevent the onset of arthrofibrosis in a pre-clinical rabbit model
(Aim 1) and (ii) define the impact of adipogenic factors, including Adiponectin and its mimetic AdipoRon, on
myofibrogenesis and decipher the mechanisms by which the adiponectin-axis counteracts myofibroblast
differentiation (Aim 2).
These studies are impactful as development of novel and non-surgical therapeutic measures that prevent and/or
treat arthrofibrosis will reduce complex, unpredictable, painful, and costly revision TKAs. Our studies provide
conceptual innovation as a pre-clinical model of arthrofibrosis will be used to test if local AdipoRon delivery in
the knee can prevent disease onset. In addition, we will define the role of the adipogenic milieu and of adiponectin
signaling activation on myofibroblast differentiation using primary human cell culture models. Overall, we aim to
establish novel therapeutic approaches to combat the onset and progression of arthrofibrosis.

Public health relevance
PROJECT NARRATIVE Joint stiffening (arthrofibrosis) is a debilitating complication following total knee arthroplasty, which is a very common surgery in the United States, with limited treatment options. While sustained inflammation and aberrant tissue generation are primary manifestations of arthrofibrosis, the cellular and molecular effectors as well as biochemical characteristics of arthrofibrotic tissues have yet to be elucidated. Our studies are focused on defining mechanisms that lead to arthrofibrosis and testing new therapeutic interventions that disrupt downstream processes leading to this musculoskeletal disease.